Synthesis and Biochemical Evaluation of Ruthenium Compounds

Project Summary
Transition metal compounds have been used as therapeutic agents. However, treatment
with these compounds, for example cisplatin, can lead to drug resistance and poor efficacy.
Ruthenium has been studied as an alternative to other transition metals. The aims of this
project are to carry out the synthesis, characterization, and biochemical evaluation of
ruthenium-based compounds as potential pharmaceutical agents. Ruthenium compounds
have gained attention as potential therapeutic agents having different modes of action
against bacterial infections, cancer, diabetes and other diseases.
The overwhelming majority of pharmaceutical agents, including transition metal drugs,
either target DNA or proteins. RNA has recently received much attention as a biomolecule
in the fields of public health, medicine, and biotechnology. The rich structural diversity of
RNA and its role in numerous cellular functions have led to its emergence as an important
biological target for pharmaceutical agents. Very few studies have explored how transition
metal complexes bind to RNA molecules. The initial aim of this project is focused on the
synthesis and characterization of ruthenium complexes. The second aim of this project will
investigate the binding of ruthenium complexes to various RNA molecules. Results will
reveal the specific RNA binding sites of ruthenium complexes, their binding strength, and
the impact of binding on RNA structure and function. The ruthenium compounds
synthesized in this project are designed with the purpose of enhancing their binding to
nucleotides, improving aqueous solubility, and making them active against diabetes, and
bacteria and cancer cells.
Finally, this project will determine whether the newly synthesized ruthenium complexes
bind to dihydrofolate reductase (DHFR) enzyme and inhibit its catalytic activity. DHFR is
a crucial enzyme within the folic acid pathway. The folic acid pathway is important in the
synthesis of nucleotides, amino acids, and other cellular intermediates. DHFR enzyme has
been targeted extensively by antifolate drugs, like methotrexate, which have been on the
market for decades. Compounds synthesized in this project incorporate architectures of
different antifolate and antidiabetic drugs with the goal of improving their water solubility,
hydrogen bonding capabilities, and overall specificity.

Public health relevance
Project Narrative The rise of drug resistance against bacterial infections and diseases such as, cancer and diabetes, is a significant public health concern. Developing potent new drugs and determining their molecular targets are important research goals. Synthetic ruthenium compounds have the potential of binding and inhibiting biomolecular targets.